Neuron-astrocyte interactions mediating ethanol and noradrenergic modulation of wake-promoting vPAG dopamine neurons

PROJECT SUMMARY
An estimated 50-70 million Americans suffer from a sleep disorder, which is commonly comorbid with many
psychiatric illnesses, such as alcohol use disorder (AUD). Individuals with AUD frequently report insomnia, and
sleep difficulty significantly increases the likelihood of relapse. Despite the overwhelming need to control sleep
disturbances to aid in the prevention of relapse, the underlying physiology of wakefulness, particularly in the
context of acute and chronic alcohol use, is not well understood. The brain’s noradrenergic system mediates
many behavioral states, such as arousal, alertness, and stress. Acute and chronic alcohol exposure
differentially alter the activity of noradrenergic neurons as well as the release, synthesis, and turnover of
norepinephrine (NE) in the brain. Recently, our lab alongside collaborators delineated a novel arousal circuit
from the noradrenergic locus coeruleus (LC) to dopaminergic neurons in the ventral periaqueductal gray
(vPAGDA), where stimulation of this circuit promotes wakefulness. Acute ethanol exposure also increases
excitatory drive and the activity of wake-promoting vPAGDA neurons; however, the mechanism is unknown.
Specific activation of alpha1-adrenergic receptors (α1ARs) increases excitatory drive onto vPAGDA neurons and
subsequently causes arousal. Interestingly, α1AR expression is particularly enriched on vPAG astrocytes, and
activation of astrocytic Gq signaling is sufficient to promote wakefulness. While astrocytes are essential in
mediating synaptic transmission in other brain regions through purinergic signaling, the role of neuron-
astrocyte interactions in the vPAG during ethanol exposure requires further investigation. This F30 aims to
test the central hypothesis that purinergic transmission from neighboring astrocytes mediates the
noradrenergic modulation of vPAGDA neurons, and that ethanol potentiates this signaling. The goal is to
elucidate the mechanistic details mediating the increase in excitatory drive onto the wake-promoting vPAGDA
neurons by activation of α1ARs and the pathologic changes to the noradrenergic system following acute and
chronic alcohol exposure. In Specific Aim 1 I will utilize pharmacological and viral genetic approaches
combined with ex vivo fluorescence imaging and whole cell patch-clamp electrophysiology to examine the
neuron-astrocyte interactions underlying noradrenergic modulation of vPAGDA neurons. In Specific Aim 2 I will
use similar approaches in addition to a mouse model of chronic intermittent ethanol exposure to determine the
changes in synaptic transmission onto vPAGDA neurons following acute and chronic ethanol exposure. The
results of these studies will allow our lab, our collaborators, and others to further investigate the role of neuron-
astrocyte physiology related to sleep dysfunction in alcohol use disorder. This will further the work towards
identifying possible therapeutic targets for the development of novel therapies to alleviate disordered sleeping
and aid in relapse prevention.

Public health relevance
PROJECT NARATIVE Alcohol use disorder and sleep disorders are commonly comorbid, and dysfunctional sleep significantly increases the risk of relapse in individuals abstaining from alcohol. My project will investigate synaptic mechanisms of ethanol and noradrenergic modulation in a population of wake-promoting dopamine neurons in the midbrain. In doing so, we hope to elucidate potential novel therapeutic targets for the treatment of dysfunctional sleep in the context of alcohol use disorder.